High dimensional statistical data modeling and integration for studying regulatory variation

Project Summary
Gene regulatory programs of mammalian cells are largely influenced by long-range
chromatin interactions. We propose to develop robust and scalable statistical methods
for two critical genomic inference problems hinging upon long-range chromatin
interactions. First, the study of long-range interactions at the single cell-level with 3C-
based method scHi-C is fundamental to fully understanding cell type-specific gene
regulation. scHi-C measurements harbor unexplored biological diversity. However, these
measurements are prone to extreme sparsity, technological bias, and noise. While initial
inference methods simply focused on lower dimensional representations of scHi-C data,
lack of a scalable framework that can exploit nonlinearities in de-noising of the data
impedes key inference tasks from these experiments. We will address these critical
shortcomings by developing a novel deep generative model for scHi-C data. By de-
noising the data, these methods will improve the power with which signals of interest can
be studied. Second, while advances in sequencing and large-scale availability of
epigenome data improved the power and interpretation of genome-wide association
studies (GWAS), shortcomings in identifying which genes noncoding SNPs might be
impacting through long-range chromatin interactions hinder the translation of GWAS
findings into clinical interventions. Leveraging existing large-scale studies of diversity
outbred mice, we will develop a rigorous framework that integrates multi-omics functional
data modalities to fine-map model organism molecular quantitative trait loci and transfer
the results to humans for linking noncoding GWAS SNPs to their effector, i.e.,
susceptibility, genes. Large-scale application with type 2 diabetes (T2D) traits will deliver
candidate T2D effector genes and their regulatory loci that are amenable for
experimental follow-up. Both aims will be accomplished through a combination of
methodological development, theoretical analysis, data-driven simulation, computational
analysis, and experimental validation. Statistical resources generated from this project
will be disseminated as open-source software. Successful completion of the project will
help to ensure that maximal information is obtained from powerful scHi-C experiments
and model organism multi-omics data.

Public health relevance
Project Narrative Long-range chromatin interactions are fundamental to gene regulation. This project seeks to address some of the most critical statistical and computational deficits in studying long-range chromatin interactions. It develops novel statistical methods that can reduce noise and amplify true biological signal in noisy high throughput chromatin conformation data of single cells and innovates integrative models that can leverage model-organism multi-omics data to elucidate long-range interaction-mediated impacts of noncoding association variants on genes.